Improved Surgical Navigation Using Video-CT Registration

Abstract
In many surgical procedures, image guided surgery (IGS), also known as surgical navigation, facilitates
precise surgical manipulations near critical structures such as the brain and eye. IGS suffers from critical
limitations such as loss of precision and correspondence with preoperative imaging once surgery begins and
the anatomy is altered. These limitations may be addressed through intra-operative imaging, which effectively
“resets” the model and thus enables both improved precision of IGS as well as improved surgical decision-
making. However, intraoperative radiologic imaging has many limitations, including disruption of the workflow,
cost, and additional radiation exposure. This project aims to develop solutions to resolve limitations of IGS
without the need for intra-operative radiologic imaging. Our solutions rely upon data from a device that is
present in every procedure using IGS, namely, the endoscope. Our goal in this project is use endoscopic video
images to reconstruct surgical anatomy as it changes. This enables sustained precision in registration with pre-
operative imaging throughout the procedure by updating the anatomical model as surgery progresses. We will
achieve this by 1) using advances in computer vision to develop improved methods for continuous direct
registration between the endoscope and the CT; and 2) developing methods that continuously compute the
geometry of observed surfaces and update the preoperative CT with changes in that geometry. The technology
developed in this proposal thus enables the following: 1) precise surgical navigation using the endoscope
throughout the procedure; 2) surgical decision-making without the need for additional intra-operative imaging;
and 3) new tools to reconstruct surgical anatomy and quantitatively evaluate the extent of surgery.

Public health relevance
Narrative Image guided surgery is widely used to safely navigate around complex structures like the ethmoid bone and critical structures such as the brain; its utility is greatly enhanced when coupled with intraoperative radiographic imaging because the anatomic changes caused by surgery are clearly elucidated and can be incorporated into the surgical plan. This project will develop computational methods that exploit readily available endoscopic video to improve the accuracy of navigation and to provide intraoperative updates to the anatomic model. This technology will enhance surgical decisions in the operating room and enable precise navigation throughout the surgery without the need for additional radiologic imaging in the operating room.